Developmental Pathways to Dating Violence and Suicidal Behavior: The Healthy Teen

[unreadable] Description (Provided by Applicant) [unreadable] Importance: The goal of Healthy Teens is to increase scientific understanding of different levels [unreadable] of risk and protective factors that influence the developmental pathways (i.e., patterns of [unreadable] continuity or patterns of change over time) that children and young adolescents follow from 6th [unreadable] through 12th grade, in relation to dating violence and suicidal thoughts and behaviors. Healthy [unreadable] Teens differs from much of the extant research literature in that it: a) is a longitudinal study of a [unreadable] large sample (cohort of approximately 700 students); b) uses multiple methods (student [unreadable] surveys, teacher ratings, archival data on academic achievement and discipline, focus groups, [unreadable] and interviews; c) includes two samples of students (random and high-risk); d) evaluates a large [unreadable] number of violence-related constructs and behaviors, including risk and protective factors at [unreadable] multiple levels of an ecological framework; and e) includes students who dropped out of school. [unreadable] The unique, comprehensive design of Healthy Teens will serve to enhance our comprehension [unreadable] of the development of dating violence and its interrelation with suicidal thoughts and behaviors [unreadable] and, thus, provide a firm foundation to enhance prevention strategies. [unreadable] Objectives: Specific objectives are to: a) evaluate developmental trajectories from middle to [unreadable] high school in relation to dating and dating violence victimization and perpetration and its interrelation [unreadable] to suicidal thoughts and behaviors; b) evaluate the risk and protective factors that [unreadable] influence these developmental trajectories; and c) explore the context and meaning of dating [unreadable] violence from students' perspectives. [unreadable] Study Design: Healthy Teens is a mixed-method study that began when students were in the [unreadable] 6th grade; they are currently in the 11th grade. This study proposes to complete one more year of [unreadable] data collection (12th grade-Year 1) so that that there will be complete, comprehensive data set [unreadable] of this cohort from middle through high school. Data analyses will be conducted during Years 1, [unreadable] 2 and 3 of the proposed study. This study will employ the same data collection strategies used [unreadable] since students were in the 6th grade, that is: a) student self-reported assessments; b) teacher [unreadable] behavioral ratings of students (BASC); and c) archival data. Additionally, individual interviews [unreadable] will be conducted with a purposeful, maximum variation sample of students who have been [unreadable] victims and/or perpetrators of dating violence. [unreadable] Setting: Healthy Teens researchers will work cooperatively with school administration and staff [unreadable] to collect data in the schools, as in years past. When this is not possible (e.g., student who has [unreadable] dropped out of school), data will be collected in students' homes or another convenient location [unreadable] (e.g., public library). [unreadable] Participants: Healthy Teens has followed a cohort of approximately 700 students (currently in [unreadable] the 11th grade) in eight Northeast Georgia high schools. When students were in the 6th grade (9 [unreadable] middle schools), two types of samples were recruited: a random sample and a high-risk-foraggression [unreadable] sample. The random sample (676 students) represented the student population of [unreadable] each school; the high-risk sample (213 students) consisted of students who were considered by [unreadable] their teachers to be aggressive and influential with peers. A small number of students (107) in [unreadable] the random sample were also selected for the high-risk sample. [unreadable] Outcome Measures: All students have completed questions on dating violence norms, dating, [unreadable] and dating violence behaviors; high school students have completed questions related to [unreadable] feelings of sadness and hopelessness and suicidal thoughts and attempts. In addition, all [unreadable] students have completed an array of measures of risk and protective factors at the individual, [unreadable] family, peer, and school levels. Census data on individual neighborhood characteristics are also [unreadable] available. [unreadable] [unreadable] [unreadable]

Public health relevance
HEALTHY TEENS - DATING NARRATIVE Romantic relationships are a central aspect of adolescent development. Unfortunately, this developmental process is not easy, and many adolescents report violence from or against their dating partners. The goal of Healthy Teens is to increase scientific understanding of different levels of risk and protective factors that influence the developmental pathways (i.e., patterns of continuity or patterns of change over time) that children and young adolescents follow from 6th through 12th grade, in relation to dating violence and to suicidal thoughts and behaviors.